Molecular Repair of Diabetic Mesenchymal Stem Cells (dMSC) for Peripheral Arterial Disease

Diabetes and peripheral arterial disease (PAD) disproportionately affect our nation's Veterans. Diabetic
patients have limited collateralization and regenerative capacity in their tissues. Diabetic patients with
peripheral arterial disease have severe ischemic complications and are at grave risk of major amputation.
Reversing tissue ischemia by surgical revascularization prevents amputations, but many patients with diabetes
and peripheral arterial disease are not fully treatable by surgical revascularization. Regenerative cell-based
therapies may enable a full step forward in re-establishing or regenerating the vascular supply of the leg to
prevent amputations. We have identified a unique intracellular signaling defect in diabetic mesenchymal stem
cells that can be favorably modified to improve these cells. This proposal will test the effectiveness, durability
and then mechanism by which this approach works under diabetic conditions using relevant in vitro and in vivo
models. Positive results will be used to translate these methods to Veterans with diabetes and PAD.

Public health relevance
Limb salvage is a major health issue for Veterans with diabetes and peripheral arterial disease. The increasing incidence of diabetes and peripheral arterial disease and the clinical plateau of therapeutic options make this a critical and national issue. This proposal seeks to overcome current barriers and develop a translational platform for regenerative medicine in our Veteran population.